Regulatory T cell coordination of the mucosal NK cell response during viral infection

PROJECT SUMMARY
We continue to lack vaccines for many pathogens of public health importance, including herpes simplex virus-2
(HSV-2), human immunodeficiency virus-1 (HIV-1), and tuberculosis (TB). In many infections of public health
importance including HSV-2, the mucosal barrier is the portal of pathogen exposure, yet the regulation of
mucosal immunity is incompletely understood. The broad objective of this proposal is to achieve a more in-depth
knowledge of the regulation of mucosal immunity in the anti-pathogen immune response. Nature killer (NK) cells
at mucosal sites are critical in controlling infections. NK cells are important for resolving HSV-2 infection by
producing cytokines early after infection that activate adaptive immune responses, such as IFNg. Although NK
cells are part of the innate immune system, there is evidence suggesting that NK cells can become long-lived
memory-like cells and play an important role in secondary immune responses. NK cells remain functionally
primed in the mucosal tissue up to 30 days after HSV-2 infection. During HSV-2 infection, NK cell activation is
driven by inflammatory cytokines, and therefore must be subject to immune regulation to limit immunopathology.
Regulatory T cells (Tregs) act by suppressing immunity and are crucial to maintaining peripheral tolerance and
limiting tissue damage from excess inflammation. In the context of infection, there is evidence that Tregs
unexpectedly also play a pivotal role in orchestrating an anti-pathogen response. Tregs are necessary during
early HSV-2 infection to coordinate a productive anti-viral immune response in the vaginal tract (VT) in mice.
However, the mechanism by which Tregs coordinate early antiviral innate immunity while limiting
immunopathology remains poorly defined. While the link between NK cells and Tregs during infection is not well
understood, there is evidence that the NK cell response is altered by the absence of Tregs. We previously
published that Tregs are required for the proper homing of NK cells to the VT after HSV-2 infection. More recently,
I have generated data that Treg depletion during HSV-2 infection increases NK cell maturation providing
evidence that Tregs act in limiting NK cell response during viral infection. Thus, our rigorous prior research
suggests a dual function for Tregs in modulating NK cell responses in which Tregs are required for both
coordination of NK cell response and limiting excessive inflammation. However, the mechanisms and timing by
which Tregs modulate NK cells within mucosal tissues during infection remain to be studied. This proposed work
is essential for understanding the role of Tregs in coordinating and regulating NK cell function in mucosal tissues
during viral infection. This understanding of mucosal immunology will be crucial to informing vaccine strategies
to develop a balanced, robust, and tissue-specific immune response against viral infections, while still limiting
immunopathology.

Public health relevance
PROJECT NARRATIVE We continue to lack vaccines for many pathogens of public health importance, including herpes simplex virus-2 (HSV-2), human immunodeficiency virus-1 (HIV-1), and tuberculosis (TB). In many infections of public health importance, the mucosal barrier is the portal of pathogen exposure, yet the regulation of mucosal immunity is incompletely understood. Completion of this proposal will provide insight into regulation of the anti-viral mucosal immune response and how pathogen clearance can be achieved while preserving barrier tissue integrity.